Very-long Term Neurocognitive Outcomes in Breast Cancer Survivors (ProbC2)

PROJECT SUMMARY/ABSTRACT
Chemotherapy-related cognitive impairment (CRCI) is associated with reduced quality of life and
survival making it a significant problem that remains understudied. Research by our group and others
has demonstrated that CRCI is associated with altered brain structure and function from pretreatment
to post treatment. There is significant overlap between chemotherapy actions and physiologic
processes involved in aging. Neurocognitive have been found in patients up to 20+ years post-
treatment and work by our group and others suggests an accelerated brain aging phenotype in breast
cancer survivors treated with chemotherapy. We have also observed that patients may demonstrate
unique trajectories of cognitive impairment that require further study. Existing prospective, longitudinal
studies of cancer and cognition, including our own, have been limited to relatively short-term post-
treatment follow-ups (e.g. 6-12 months). To begin addressing these limitations, we aim to extend our
current prospective study (CA172145), which longitudinally examines cognitive function and brain
structure/function pre-surgery, 1-month post chemotherapy, and 1-year post chemotherapy. We will
continue to assess cohorts of women treated with chemotherapy, chemotherapy naïve patients, and
healthy controls at yearly intervals for 5 additional years (up to 10 years). Using non-invasive
neuroimaging methods, we will advance our original aims from the initial project to measure very long-
term neurobiologic outcomes with an emphasis on the assessment of neural connectivity rather than
specific regional changes (Aim 1). We will also examine very long-term cognitive outcomes as
measured by standardized neuropsychological testing (Aim 2). Finally, we will explore different
trajectories or subtypes of impairment and their neural phenotypes (Aim 3). The proposed project will
significantly advance the understanding of chemotherapy-related cognitive impairments by extending
our knowledge on very long-term neurobiological outcomes along with the different subtypes of
cognitive impairments and associated neural profiles following breast cancer chemotherapy.

Public health relevance
PROJECT NARRATIVE During the last decade there has been progress in defining the neurocognitive changes associated with breast cancer from pretreatment to post treatment, but little is known about how the neurocognitive changes beyond 1-3 years post treatment. It is possible that cancer related cognitive impairments result from accelerated aging processes, and if so, we need a better understanding of survivors’ neurocognitive changes beyond 3 years. To begin addressing these limitations, we aim to extend our current prospective study (CA172145), which longitudinally examines cognitive function and brain structure/function pre-surgery to 1-year post chemotherapy. In the proposed competing renewal study, we will continue to assess our breast cancer cohort at yearly intervals for 5 additional years providing unique longitudinal data up to 10 years post-chemotherapy. The proposed project will extend our knowledge on very long-term neurocognitive outcomes following breast cancer chemotherapy